Admin Core

CORE SUMMARY/ABSTRACT
Three Projects and two Cores within this P01 receive support by the now well-established Core A. Based on
our two decades of experience with such oversight, we believe the notion of “success” for the overall program
depends on the P01 having an effective Administrative Core component as a central element of
fiscal/regulatory coordination, human subject recruitment, and scientific guidance/external evaluation. With this
belief, the four goals of Core A are as follows: 1) Coordinate the budgetary and fiscal aspects of the program.
The proposed program involves direct cost disbursements to investigators of Projects 1, 2, & 3, as well as
Cores A and B; hence, careful oversight represents an absolute administrative requirement. 2) Facilitate
communication among investigators within the program. This aim takes a pragmatic form through Core A's
implementation of a variety of functions ranging from organizing regularly scheduled meetings between
program investigators to training of Project investigators by the program's Cores. 3) Coordinate, as a Program
Executive Committee, ongoing feedback with regard to the directions of the individual Projects and Cores, the
goals and activities of the P01, and respond to input provided by the External Advisory Board — individuals
who provide on-site visits to the University of Florida as well as teleconference based reviews — for the
purpose of maximizing both the progress and success of the program. 4) Organize the collection of human
materials, generate appropriate data sets, provide statistical support to the program, assure compliance with
appropriate regulatory bodies and edicts (e.g., Institutional Review Board, Health Insurance Portability and
Accountability Act), and facilitate communication of program results. In addition to the aforementioned
functions, the administrative staff of the program will also be responsible for communication with the NIH staff,
as well as for assistance with publications and presentation of program results. It should be noted that the
P01's Program Executive Committee has reviewed changing priorities and advances in the field of type 1
diabetes (T1D) and with this renewal application, organized itself to address the growing needs for: 1)
identifying key processes at the intersection of β-cell biology and anti-β-cell immunity; 2) understanding
genotype/phenotype interactions in T1D that impact immune responsiveness; 3) developing improved
biomarkers (immune/metabolic/genetic) reflective of key pathogenic processes; and 4) discovering methods
that would impart immune modification capable of preventing/reversing T1D. Directed/collaborative activities to
achieve these goals, taken together with the successful completion of these P01 studies, should continue to
prove beneficial for improving our understanding of the immunological and genetic contributions critical to the
pathogenesis of T1D, identifying immune/genetic markers that enhance our ability to monitor the disorder's
natural history and eventually, developing immunotherapies capable of preventing or reversing the disease.